Small Molecule Signaling in Caenorhabditis elegans

Project Summary
The nematode Caenorhabditis elegans is one of the most important model organisms for biomedical
research, because of its biological tractability and because much of its physiology and behavior relies
on signaling pathways that are conserved in humans. The goal of this project is to complement the
highly developed genomics and genetics of C. elegans with a comprehensive structural and functional
characterization of its metabolome. In recent work we have shown that C. elegans utilizes small-
molecule architectures of unanticipated diversity and complexity in endocrine and exocrine signaling
that control almost every aspect of its life history, including development, aging, stress resistance, and
a wide range of behaviors. One major focus of our investigations is the elucidation of the biosynthesis
and perception mechanisms of newly identified small molecule signals, which will reveal how
metabolism and conserved signaling pathways interact to control phenotypes. Of particular interest
are (i) the roles of recently identified endogenous agonists of the nuclear receptor NHR-49, a key
regulator of lipid metabolism and functional ortholog of vertebrate PPARα, (ii) male germline-
dependent metabolites that accelerate development and aging via conserved pathways, including
homologs of mammalian steroid receptors, and (iii) our recent discovery of a modular glucosides that
appear to function as a “second layer” of neurotransmitter signaling. In addition, we will investigate the
biological functions of a new family of nucleoside derivatives we discovered that may interact with
purinergic signaling. Another focus area will be the influence of dietary bacteria on C. elegans small
molecule signaling, motivated by our discovery of unexpected roles for bacterial metabolites, e.g. in
modulating fat metabolism via NHR-49 or in serotonin signaling. Central to the proposed research is
the use of synthetic samples and derivatives of identified signaling molecules for bioassays, mutant
screens, and transcriptomic studies, as well as the in-house developed metabolomics platform
(Metaboseek), which greatly accelerates compound identification and functional annotation.
Successful conclusion of this project will provide a structural and functional annotation small molecule
signaling networks in C. elegans, substantially increasing our understanding of conserved pathways
that control development, aging and metabolism, as well as corresponding disease-relevant pathways
in mammals. The small-molecule knowledge generated will not only enable future efforts aimed at
more varied chemical genetic screens exploring additional aspects of the biology and ecology of C.
elegans, but also of nematode species relevant in agriculture or medicine. Furthermore, methodology
developed for characterizing C. elegans signaling molecules will facilitate similar studies toward
structural and functional characterization of small molecule metabolites from other model organisms.

Public health relevance
Project Narrative The physiological changes associated with aging and metabolism underlie increases in the incidence of many diseases, including, diabetes, cancer, neurological disorders, heart disease, and osteoporosis. In nematodes, several different classes of small molecules have been shown to significantly retard the effects of ageing and modulate fat metabolism. The proposed study aims to investigate the biological mechanisms through which these and other endogenous compounds modulate lifespan, development, and metabolism in nematodes, which will contribute to our understanding metabolic dysfunction and age-related decline in humans.